Regulation of calcium homeostasis in the pancreatic beta cell

PROJECT SUMMARY/ABSTRACT
Diabetes mellitus affects nearly one in four Veterans and over 463 million individuals worldwide. Inadequate
insulin secretion from the pancreatic β cell plays a primary role in diabetes pathogenesis; however, the
mechanisms responsible for β cell failure in diabetes remain poorly understood. The long-term goal of our VA-
funded research program is to identify how altered β cell calcium (Ca2+) homeostasis contributes to diabetes
pathophysiology. During the last funding cycle, we identified a previously unappreciated role for impaired store-
operated calcium entry (SOCE) in human and rodent models of type 2 diabetes. SOCE is a process that is
activated in response to endoplasmic reticulum (ER) Ca2+ depletion and is initiated when Ca2+ dissociates from
the ER Ca2+ sensor, STIM1, leading to STIM1 oligomerization and translocation to the plasma membrane. Here,
STIM1 complexes with the Ca2+ selective ion channel, Orai1, leading to Orai1 opening, Ca2+ influx from the
extracellular space, and subsequent transfer of Ca2+ into the ER. To study the in vivo role of SOCE, mice with
β cell specific loss of STIM1 (STIM1Δβ) were generated and challenged with a high fat diet to model type 2
diabetes. Our results revealed an unusual sexually dimorphic phenotype, where female (but not male) STIM1Δβ
mice displayed significantly impaired glucose tolerance as well as reduced insulin secretion and β cell mass that
was associated with reduced expression of key β cell identity markers and a reciprocal increase in α cell mass.
Unbiased as well as targeted transcriptional analysis revealed a reduction in G-protein coupled estrogen receptor
(GPER) expression that was linked with reduced estradiol and GPER-mediated signaling. This finding was
notable because loss of endogenous estradiol signaling has been linked with reduced β cell function and
increased diabetes susceptibility, while estradiol has beneficial effects in both male and female β cells. Against
this background, we hypothesize that impaired SOCE leads to reduced estradiol-mediated signaling through
GPER, resulting in β cell de-differentiation and reduced β cell function in type 2 diabetes. To test this hypothesis,
two Specific Aims are proposed in this VA Merit renewal application. In Aim 1, lineage tracing experiments will
be performed to track the fate of β cells in female STIM1Δβ mice fed a high fat diet, allowing us to define whether
there is bona fide β cell de-differentiation in this model. We will test whether mice with a β cell specific deletion
of Orai1 (Orai1Δβ) exhibit a similar sexually dimorphic phenotype and loss of β cell identity. Finally, we will
determine whether naturally occurring loss of function mutations in STIM1 and Orai1 impact directed
differentiation of induced pluripotent stem cells into β cells. In Aim 2, experiments will be performed to determine
how GPER and SOCE interact to regulate β cell function. Here, an ovariectomy model will be leveraged to test
whether endogenous estradiol signaling is required for the maintenance of β cell identity in the setting of diet-
induced obesity, and we will determine how β cell specific GPER deletion impacts β cell function and
differentiation status. A specific pharmacological agonist of GPER will be used to test whether β cell de-
differentiation is reversible in STIM1Δβ, Orai1Δβ, and ovariectomized mice and in human islets from donors with
T2D. Using the diet-induced obesity model, we will determine if GPER agonists have beneficial and/or distinct
effects in the male islet, and we will complete mechanistic experiments aimed at testing the functional interaction
between SOCE and GPER signaling. Across all Aims, questions will be translated into human model systems
by utilizing human islets from donors with and without diabetes, pancreatic sections from pre- and post-
menopausal female organ donors, and iPSCs from humans with STIM1 and Orai1 loss of function mutations.
The translational impact of this work will be the identification of pathways that can be targeted clinically to improve
β cell health in diabetes with the guiding principle of personalized therapeutic approaches that consider disease
specific mechanisms that may differ and overlap between males and females.

Public health relevance
PROJECT NARRATIVE Diabetes mellitus is a disorder of glucose homeostasis that affects nearly one in four Veterans and is a leading cause of blindness, kidney failure, and cardiovascular disease. Female veterans are at high risk for the development of diabetes, and the number of females receiving care in the VA is growing, suggesting that increased expenditures will be needed to care for this population. Pancreatic β cell dysfunction plays a central role in the pathogenesis of diabetes, yet current therapies do little to improve β cell health. The goal of this proposal is to define how impaired store operated calcium entry interacts with estrogen signaling to cause β cell de-differentiation and to test how alterations in these pathways contribute to diabetes development. The translational impact of this work will be the identification of novel pathways that can be targeted clinically as a means of preserving β cell function, survival, and identity in diabetes.